Biomechanical and biomolecular characterization of large extracellular vesicles

PROJECT SUMMARY/ABSTRACT
Extracellular vesicles (EVs) are cell-derived, membrane-bound vesicles that carry various biomolecules
(proteins, nucleic acids, lipids) and are found in noninvasive liquid biopsies. They play important roles in cell-to-
cell communications as molecular messengers, meaning EVs are also attractive circulating biomarkers for
molecular diagnosis of various diseases and carriers for therapeutics. Most previous studies have focused on
the biomolecular contents of small nanoscale EVs (also called exosomes). There is less understanding of
EVs’ mechanical properties and the molecular characteristics of microscale large EVs (L-EVs). EV origins vary
widely, and their functions are harder to determine. Investigating EV functions and downstream clinical
applications requires rigorous approaches of separating and classifying EVs. The EV field is still determining
the characteristics of EV subpopulations and how to best separate them into groups. The overall goal of this
project is to investigate L-EV subtypes using our microfluidic technology that will be advanced to measure the
biomechanical and biomolecular properties of single L-EVs. The two specific aims propose to investigate L-EV
heterogeneity and subtypes from different GBM-associated mutations (e.g., EGFR, EGFRvIII, and IDH1
mutations) and explore the clinical value of multiplex L-EV characterization from plasma samples. The
collaborative team has complementary expertise (Dr. Dahl at UMass Boston for microfluidics and
biomechanics and Dr. Im at Massachusetts General Hospital for imaging and molecular characterization of
EVs). Undergraduate researchers from UMass Boston will be trained in biotechnology lab techniques at both
UMass Boston and MGH, acquire and analyze data for this project, and be fully integrated into the
collaborative research team through their participation and presentation of their work at biweekly project
meetings and twice-a-year in-person project symposiums. This proposed work will deepen our understanding
of EV biology, especially with the biomechanical properties of EVs, along with their roles as biomarkers. By
correlating L-EV stiffness to its biomolecular content, we seek to explain the biomolecular origins of EV
stiffness and assess the feasibility of using both physical and chemical properties as biomarkers to classify
cancer subtypes more accurately.

Public health relevance
PROJECT NARRATIVE Extracellular vesicles (EVs) are cell fragments found throughout the body that carry various biomolecules (proteins, nucleic acids, lipids) and are potential circulating biomarkers for diagnosing various diseases from simple blood samples and potential drug delivery vehicles for delivering drugs to hard-to-reach places. Before EVs can be leveraged in these ways, more research on their basic properties and better tools to perform these characterizations are needed. The overall goal of this project is to investigate new EV subtypes and their clinical potential using our microfluidic technology that will be advanced to measure the biomechanical and biomolecular properties of single L-EVs simultaneously.